Metabolic regulation of Neutrophil Extracellular Traps (NETs) in TBI

Abstract: Traumatic brain injury (TBI) is a significant global public health issue, leading to high mortality
rates, disabilities, and substantial socioeconomic burdens. TBI results in the loss of AMPKα activity, disruption
in regional metabolism, persistent changes in metabolic rates and energy utilization, and elevated glycolysis
which enhance the pentose phosphate pathway and promote inflammation. The association between metabolic
changes in the brain tissue and the subsequent neutrophil activation and inflammation remains unclear. In this
study, male/female C57BL/6 and AMPK-KO mice were subjected to CCI-induced TBI or sham surgery. After
assessing behavioral impairments, the mice were sacrificed for the histological and biochemical assay. Our
preliminary results show that post-TBI administration of AMPKα1 attenuates the formation of NETs,
downregulates inflammation, and promotes neuroprotection. These promising findings suggest that further
investigation into the mechanism of neuroprotection by specific AMPK activators such as A-769662, could lead
to new therapies for human TBI, potentially extending the therapeutic window for rescuing neurons. The overall
goal of the current proposal is to identify the optimal doses and timing for the benefit of A-769662 and to elucidate
how AMK activation protects the brain by reducing NETs formation and inflammation following TBI. we
hypothesize that the loss of AMPK activates circulating neutrophils to form NETs and incites inflammation,
contributing to aggravated outcomes. Modulating AMPK by targeting neutrophil-primed NET formation could
have therapeutic potential for protecting against neuronal injury and functional deficits in a preclinical mouse
model of TBI. The proposed preclinical studies aim to be the first to determine the efficacy of A-769662 in
protecting the brain following TBI. Our hypothesis will be tested through the following aims: Aim 1: Determine
the role of AMPK modulation on the functional outcomes and neuropathology after TBI. Aim 2: Determine the
effects of AMPK modulation on NETs formation and inflammation using genetically modified mouse models. Aim
3: To identify the alternate novel source(s) of cellular fuel driving the hyper-inflammatory role of AMPK-KO
neutrophils. These studies will advance the field by providing critical insight into the therapeutic potential of
AMPK modulation in TBI.

Public health relevance
Project Narrative: The proposed research aims to enhance our understanding of how AMPK activation regulates metabolism and the inflammatory role of NETs following TBI. This work is crucial for public health, as the findings develop precisely targeted therapies and treatments for TBI, ultimately improving their outcome.